Role of Tregs in the acquisition and maintenance of Tconv anergy in transplantation tolerance

Summary
Donor-specific transplantation tolerance is an important goal for improving the quality of life of transplant
patients, as it eliminates side-effects from chronic immunosuppression. Transient regimens that use a blocking
CD154 antibody have been shown to promote donor-specific transplantation tolerance in mice and non-human
primates. Although initial clinical trials testing CD154 had been halted due to thromboembolic complications in
humans, new humanized Fc-mutated antibodies avoid FcR cross-linking and platelet aggregation and are safe.
Three such antibodies are in clinical trials, frexalimab (Sanofi), tegoprubart (AT-1501, Eledon Pharmaceuticals),
and TNX-1500, with both TNX-1500 and AT-1501 being slated to start phase 2 trials in kidney transplantation.
As such, there is considerable renewed interest in mechanistic experiments to fully understand the
consequences of CD154 therapy. We and others have shown that transient administration of CD154, when
in combination with injection of donor splenocytes (DST) as a source of systemic alloantigen, results in long-
term donor-specific transplantation tolerance of fully mismatched cardiac allografts in mice. This treatment
expands Tregs, prevents germinal center formation and therefore development of donor-specific antibodies
(DSA), and results in a hypofunctional state of alloreactive conventional T cells (Tconvs) akin to anergy. We have
shown that acquisition of this T cell anergic state requires both blockade of CD154/CD40 interactions and
persistent expression of the cognate alloantigen in the graft. Our preliminary results also show that
CD154+DST-mediated graft acceptance and expansion of Tregs both depend on the presence of classical
dendritic cells 1 (cDC1), as they fail to occur in IRF832 mice that lack cDC1s. Although we initially thought that
Tregs would function as suppressor cells in this model (reducing the activation of functional Tconvs), our
preliminary results reveal an exciting new property of Tregs: their ability to program and maintain anergy in
alloreactive Tconvs. Indeed, CD154+DST fails to induce alloreactive Tconv anergy in mice lacking Tregs, and
Treg depletion long after establishment of tolerance reinvigorates Tconvs, along with de novo DSA development.
We hypothesize that the crosstalk between Tregs, cDC1s and Tconvs during the induction of transplantation
tolerance is essential to program alloreactive Tconvs into an anergic state, as well as to maintain this state when
established. This hypothesis will be tested in the context of the following Specific Aims.
Specific Aim 1. To elucidate the mechanisms by which Tregs program alloreactive T cell anergy
during the induction phase of transplantation tolerance. Specific Aim 2. To establish the mechanisms by
which elimination of Tregs at the maintenance phase of tolerance triggers alloreactive T cell
reinvigoration. This project will define a new property of Tregs (driving Tconv anergy) and establish the role of
cDC subsets in this function at the initiation and maintenance of tolerance. This has implications beyond
transplantation, in autoimmunity and cancer, for how to manipulate Tconv function.

Public health relevance
Project Narrative Donor-specific tolerance can make transplanted organs more successful and remove the need for long-term immunosuppressive drugs and their side effects. Anti-CD154 antibodies have shown promise in achieving this tolerance in mice and non-human primates and are now being tested in humans for autoimmune diseases and solid organ transplantation. Our study focuses on a new feature of regulatory T cells (Tregs) that helps inactivate graft-reactive T cells, which is linked to long-term acceptance of the transplant.